Integrating the exposome and methylome to inform brain molecular changes in ADRD across established diverse cohorts.

Project Summary
This is an application for an administrative supplement to enhance the outcome of the parent grant: U01
AG046139 “A Systems Approach to Targeting Innate Immunity in AD”. This Administrative Supplement aims to
expand the multiomics profiling in this cohort and enable curation of exposome variables from existing
brain bank records. The design of our unique study cohort in the parent award enables us to perform comparative
analysis of control (no pathology), PathAg, (Pathologic Aging, amyloid+), AD (tau+, amyloid+) and PSP
(progressive supranuclear palsy, tau+) providing a framework to identify therapeutic targets that play a role in
the transition to different disease neuropathologic stages of AD. Further, comparisons between two brain regions
(TCX=affected and CER=largely spared in AD) and between AD and PSP can help distinguish whether the
molecular changes identified are likely a cause or consequence of pathology. We have collected multiomics
measures in ~350 study participants, including genetic (WGS), transcriptomic (RNAseq) and epigenomic (ChIP-
Seq) data. In collaboration with other consortia members, proteomic, metabolomic and lipidomic measures
were/will also be collected. The study cohort in the parent award is focused on non-Hispanic White (NHW)
individuals. Through the AMP-AD diversity initiative supplement, we expanded this study to understudied
racial/ethnic minority cohorts comprising African American (AA) and Latin American (LA) participants. These
efforts have generated complementary genetic, transcriptomic and proteomic measures on >200 diverse
individuals. However, complementary DNA methylation data is currently lacking from both the parent (NHW)
and the diversity supplement (AA, LA) cohorts. The samples in both cohorts are from the Mayo Clinic brain bank
and have undergone in-depth neuropathological examination. A similarly in-depth review of available records to
curate data on demographic, lifestyle (education, smoking and alcohol consumption), comorbid diseases,
as well as specific neuropathological findings indicative of cerebrovascular disease is currently lacking. We
hypothesize that the exposome interacts with the epigenome to drive gene expression changes which may
underlie regional, cellular and ethno-racial vulnerabilities to neuropathology and ultimately neurodegenerative
disease. The goal of this Supplement is to extract and collect exposome and DNA methylation data respectively
for participants in the Mayo Clinic AMP-AD cohorts. Our specific aims are: 1. Identify exposome variables in an
established post-mortem cohort of multi-ethnic participants with existing and new (methylome) brain multi-omics
data. 2. Discover differentially methylated regions in brain associated with AD/ADRD diagnosis, neuropathology,
and exposome phenotypes. 3. Identify impacts of AD, related neuropathologies and exposome phenotypes on
the DNA methylation profile of key brain cell types in AD. We expect to identify differentially methylated
regions (DMRs) that reveal the molecular mechanisms underlying brain regional and cellular
vulnerabilities in AD and their interactions with exposome and race/ethnicity that may drive this.

Public health relevance
Project Narrative In this administrative supplement, we aim to enhance the Mayo Clinic AMP-AD cohorts of Non-Hispanic White (NHW), African American (AA) and Latino American (LA) individuals by expanding multiomics profiling and enabling curation of exposome variables from existing brain bank records. We will perform integrative analysis of social, health and lifestyle (exposome) variables with potentially modifiable epigenomic measures (DNA methylation) and compare results across differentially affected brain regions (superior temporal gyrus and cerebellum), isolated brain cell populations (neurons/glia/microglia) and diverse populations (NHW/AA/LA). By collecting these data and analysis results, and sharing these, this proposal will enable our team and the research community to perform analysis that addresses key questions regarding the role of the exposome and methylome in ADRD across multi-ethnic cohorts.